Expanded SPF Rhesus Macaque Breeding Colony for AIDS Research

Overall: Project Summary
The Oregon National Primate Research Center's (ONPRC) expanded SPF (eSPF) Indian-origin rhesus
macaque breeding colony was developed to support research focused on AIDS-defining opportunistic co-
infections. The objective of this application is to maintain the ONPRC eSPF rhesus macaque breeding colony
to produce well-characterized, Indian-origin rhesus macaques free of a broad number of enzootic and zoonotic
agents that have the potential to confound research or pose a hazard to staff. The objective of this application
is to request funds for continued support and maintenance of the eSPF Indian-origin rhesus monkey breeding
colony. The specific aims address the components specified in the funding opportunity announcement and are
divided into the Overall program, Husbandry and Management Core, Viral Testing Core, and MHC Genetic
Typing Core. Program income and ONPRC funds will be used to support components of the program not
covered by grant funds including per diem for colony animals in excess of the animals supported by this
application, additional testing required for those animals, infrastructure repairs and improvements, veterinary
clinical and pathology support, behavioral management support, and portions of genetic testing.

Public health relevance
Overall: Project Narrative The comprehensive objective of this application is to increase the capacity of the ONPRC AIDS Research expanded SPF Breeding Colony to produce well-characterized Indian-origin rhesus macaques free of a broad number of enzootic and zoonotic agents to enhance their usefulness as a resource for NIH-funded, HIV/AIDS research.